Post-Tuberculosis Lung Disease in Youth with and without HIV Globally

PROJECT ABSTRACT
Post-tuberculosis lung disease (PTLD) is a major cause of chronic disease globally. Data are lacking, however,
on the prevalence of PTLD and targets for its prevention in youth (ages 15-24), who are vulnerable to care
engagement challenges and social determinants that may increase risk for PTLD. Tuberculosis (TB) has
tremendous health burdens for youth and is a leading cause of death in this age group. Our long-term goal is to
implement youth-focused TB services that target the drivers of PTLD, optimize care engagement, and promote
long-term lung health and well-being. Our objective is to establish the prevalence of PTLD in youth, identify
modifiable patient-level and environmental risk factors, and assess the effect of PTLD on youth quality of life.
Our central hypothesis is that PTLD is prevalent in youth and has associated modifiable risk factors and quality
of life impacts that can be targeted with tailored interventions and novel care models. The project will leverage
the Tuberculosis Sentinel Research Network (TB-SRN) of the International epidemiology Databases to Evaluate
AIDS (IeDEA). TB-SRN is enrolling 2,600 people aged ≥15 with pulmonary TB, with or without HIV, in 11
countries, and following them from TB treatment initiation to 12 months post-treatment. Assessments span
clinical, adherence, lung health, mental health, substance use and social determinant domains. We will enhance
existing procedures at 7 Youth TB-SRN sites in 6 African countries. Activities at Youth TB-SRN sites will ensure
robust analyses of PTLD in youth, through: 1) enhanced data collection on lung health, air pollution, quality of
life and well-being; 2) additional enrollment of youth with and without TB, to target 600 total; and 3) youth-friendly
supports for study retention. In Aim 1, we will identify PTLD prevalence and risk factors among youth. Persistent
pulmonary function impairment at 12-months post-TB treatment (and at 24-months in secondary analyses) will
be tested for association with clinical, care engagement, and substance use factors. Pulmonary function will be
compared in youth with and without TB. In Aim 2, we will assess air pollution as a risk factor for PTLD in youth.
We will add actionable air pollution data to TB-SRN procedures. In 180 youth with TB, 72-hour personal fine
particulate matter (PM2.5) exposure will be measured at month 2 of TB treatment, at end of treatment, and 6- and
12-months post-TB treatment. Among 180 youth without TB, PM2.5 exposure will be measured at two timepoints,
to enable analyses of TB and air pollution as drivers of lung health. In Aim 3, we will evaluate the impact of PTLD
on youth quality of life. Data on health-related quality of life and mental and social well-being will inform the
development of care models and interventions to mitigate and manage PTLD. We evaluate persistent pulmonary
function impairment for association with health-related quality of life (by EQ-5D-5L) at 12-months post-treatment.
Quality of life will be compared in youth with and without TB. Study findings will address a critical knowledge gap
about PTLD prevalence in youth and identify key targets for interventions to prevent or mitigate PTLD, as well
as foci for strategies to alleviate the detrimental impacts of PTLD on youth quality of life and well-being.

Public health relevance
PROJECT NARRATIVE Youth ages 15-24 years face tremendous health burdens from tuberculosis (TB)—the leading infectious cause of death globally—yet are neglected in TB research and care. As post-TB lung disease (PTLD) is now recognized as a major cause of chronic disease, data are needed to understand its impact on youth, and modifiable targets for its prevention in this vulnerable age group. The objective of this project is to establish the prevalence of PTLD in youth, identify modifiable patient-level and air pollution risk factors, and assess the effect of PTLD on youth quality of life.